A new mechanism of hepatocyte proliferation under stress

The goal of this project is to elucidate a new mechanism for compensatory hepatocyte proliferation
under stress. Liver regeneration in mammals has been extensively interrogated, although it is unclear how
hepatocytes with proliferative signaling defect strive to proliferate in response to hepatic damages. To
address this question, we investigated cellular dynamics in regenerating livers with hepatocyte-specific
deletion of Shp2, a signal transmitter of receptor tyrosine kinases. Following partial hepatectomy (PHx), a
few Shp2-deficient hepatocytes grouped together, and proliferated in colony-like structures. These
proliferating hepatocytes in colonies were characterized by high levels of CD133 expression but lack of other
progenitor cell markers such as EpCAM, Sox9 or AFP. The CD133+ hepatocytes apparently communicated
via tight cell-cell contact and CD133+ vesicles. The hepatocyte clusters emerged transiently in Shp2-deficient
livers following PHx and disappeared quickly after completion of liver regeneration.
CD133 has been known as a biomarker for stem/progenitor cells and also as a physical marker for
cancer stem cells (CSCs), although its function and mechanism are poorly understood. Based on the
preliminary results, we hypothesize that CD133-mediated intercellular communication is an inherent function
with which cells strive to proliferate under proliferative signaling deficit, given that cells strive to survive via
the process of autophagy under nutritional deficit. To test this hypothesis, we propose three Specific Aims.
Aim 1 is to characterize the distinctive CD133+ hepatocyte proliferation pattern in livers deficient for different
proliferative signaling molecules. Aim 2 is to determine the functional requirement of CD133 and CD133+
vesicles for compensatory hepatocyte proliferation. Aim 3 is to investigate this compensatory cell proliferation
mechanism in drug resistance of cancer cells. Success of this project will elucidate a long-sought mechanism
of CD133 function in normal and cancer cell proliferation under stress, independent of stemness, which we
discovered unexpectedly in preliminary experiments.

Public health relevance
The focus of this project is on deciphering the molecular mechanisms of compensatory hepatocyte proliferation in liver regeneration following hepatic damages. Our preliminary data have suggested a new function of CD133, a well-known biomarker in stem cells and cancer stem cells, in mediating intercellular communication to compensate deficit in intracellular proliferative signaling. Success of this project will elucidate a previously unappreciated inherent function of normal and cancer cells, which may be implicated in drug resistance of cancer.